ANTIHIV ACTIVITY OF 60MG DAILY DOSE ADEFOVIR DIFIVOXIL IN HIV INFECTED PATIENTS

Study has been completed at all sites. Results show that treatment with 60 mg monotherapy of Adefovir provides statistically significant anti-HIV activity compared to placebo in treatment naive patients. In addition, patients receiving Adefovir 60 mg once daily showed a significant reduction in the incidence of nephrotoxicity as compared to those receiving 120 mg.